MRS ASSESSMENT OF MUSCLE GLYCOGEN UTILIZATION DURING PROLONGED EXERCISE

This study has been designed to assess muscle glycogen utilization during prolonged exercise. We are hoping to understand the human physiology during prolonged exercise.